Self-control and alcohol problems: Psychological mechanisms

To enhance understanding of alcohol disorder etiology, a theory-based, multi-level model of self control, goal-setting, and alcohol consumption and use disorder symptoms will be tested.

Public health relevance
This research will increase understanding of the development of alcohol-related problems, an important public health concern. It tests a cohesive model linking individual differences in self-control and alcohol-related behaviors. Interventions can be most cost efficient and effective when guided by a solid understanding of the psychological mechanisms underlying problematic alcohol use.